Husbandry and Transgenics Core

SUMMARY / ABSTRACT ? Husbandry and Transgenics Core The core will support the needs of the U19 by developing new methods for large scale culture of Berghia and Aiptasia animals, and by supplying Berghia expressing fluorescent fusion sensors, from injected mRNA or from DNA, through transgenesis. Although insertion, editing and stable expression of transgenes into animal genomes has had a transformative impact on modern biology, a major factor limiting ongoing application of marine animals in biomedical research is the lack of genetic tools for manipulating gene function. This core will develop several innovations to supply researchers in the Berghia Brain Project with wildtype and transgenic animals. Thus, the core will develop several tools necessary for the use of Berghia as a bona fide marine model system for neuroscience.